LUTEOLYTIC PROSTAGLANDINS

The objective of the present proposal is to synthesize and evaluate prostaglandin analogs related to natural PGF2Alpha as potential luteolytic agents. We plan to synthesize in optically pure from 12-hydroxy-16(S)-fluoro PGF2Alpha, 12-hydroxy-16(R)-fluoro PGF2Alpha, 12-hydroxy-14-fluoro PGF2Alpha, 12-hydroxy-16;16-difluoro PGF2Alpha, 12-hydroxy-16-phenoxy-17,18,19,20-tetranor PGF2Alpha, 12-hydroxy-16(3-chlorophenoxy)-17,18,19,20-tetranor PGF2Alpha, and 12-hydroxy-16[3-(trifluoromethyl)phenoxy]-17,18,19,20-tetranor PGF2Alpha.